Biostatistics and Data Science Facility Core

Project Summary
The mission of Mount Sinai’s P30 Center on Health and Environment Across the LifeSpan (HEALS) is to
accelerate team science–based research utilizing life course–informed models of health. The Biostatistics and
Data Science Facility Core (BDSFC) plays a key role in that mission by modeling complex exposure and
phenotype data generated by Center Members across a spectrum of study types (basic, clinical, epidemiologic)
to integrate environment and health outcomes. Services include standard data analysis as well as developing
methods to address our Center’s research themes (exposomics, mixtures and clinical environmental research).
Environmental conditions are common and higher rates of poor air quality, poor water quality, poor nutrition
and exposure to toxic chemicals clearly play major roles in the etiology of chronic diseases. By embracing a life
course approach, our Center promotes research that addresses both early life environment and the later life
environments that determine developmental health trajectories. We also emphasize the complexity of
environmental health which crosses space (geospatial variability) and time (longitudinal time series effects, life
stage effects, etc) while bridging public health (i.e. prevention of disease) with clinical medicine (disease
diagnosis and treatment variability). Our approach is based upon the fundamental principle that “all diseases
are influenced by environment.” While we offer standard data analytic services (e.g., linear models, longitudinal
mixed effects models, power calculations, study analysis planning) the statistical methods and study designs
needed for analyzing the complex, high-dimensional data that arise in much of our Center’s work are still
relatively new and require knowledge of advanced statistical techniques and the ability to curate and interpret
complex biologic data. This type of expertise is maintained by the faculty of the BDSFC. Core faculty and
researchers engage in research motivated by questions and methodological challenges that arise from center
collaborations and innovations including many developed by our Center Cores. Core faculty and staff provide
statistical and data science training for postdoctoral fellows working on environmental health sciences (EHS)
related projects. Providing such services via a core facility allows the P30 Center to build and maintain
specialized resources (e.g., expertise in measuring and advancing statistical methods related to evaluation of
environmental mixtures). Thus, to support the overall goals of the P30 Center, the BDSFC proposes the
following specific aims: (1) to ensure that Center projects are grounded in sound biostatistical/data science
principles and use state-of-the-art methods for design and analysis of EHS data; (2) to conduct mission-critical
biostatistical/data science methods research for further quality assurance of all research and data analysis
methods; and (3) to assist in the training of biostatistical/data science principles and analysis methods to
Center investigators, fellows and post-doctoral trainees.